Foundational Investigations into Bacterial Surface Glycan Dynamics

Project Abstract
Bacteria have existed for millions of years and have evolved sophisticated methods of
communication. One primary mechanism is through the glycans on their surface, which facilitate
interactions between bacterial cells and enables their invasion into host cells. Obtaining a
fundamental understanding of these glycan interactions offers an avenue to stop bacterial
invasions and develop new therapeutic interventions. By introducing advanced computational
techniques, we will elucidate the multifaceted world of bacterial surface glycans, bridging the gaps
in our current understanding and advancing new avenues in glycobiology research. These goals
align with our lab’s mission of computationally modeling biological interfaces:
• Constructing In Silico Libraries of Bacterial Surface Glycans: Our goal is to develop a
searchable and publicly available in silico glycan library. Within the first five years, we will
focus on amino sugars and essential bacterial surface glycans, including LPS serotypes,
tailored for docking studies designed for both computational and experimental researchers.
Beyond five years, we will continuously update and add to this library including peptidoglycans
and o-linked glycans.
• Elucidating the Foundations of Glycan-Collectin Dynamics: Our goal is to create design rules
for glycan-collectin dynamics setting the foundation for the "Collectin Designer" software tool.
Within the first five years, we will focus on modeling, analyzing, and assessing the interactions
of bacterial surface glycans with two human collectins. Beyond five years, we will expand to
the other four human collectins and continue adding to the design rules which will lead to the
creation of the Collectin Designer software.
• Developing a Process to Optimize Bacterial Glycan Interactions with Collectins using SP-D
Interaction with Pseudomonas aeruginosa (Pa) Glycans as a Model System: Our goal is to
develop a process to optimize bacterial glycan interactions with collectins. Within the first five
years, we will design a theoretical SP-D that binds more effectively to the LPS and pilin
structures of Pa. We will test the efficacy of binding through in vitro binding assays. Beyond
five years, we will refine our SP-D model and test in vivo.
The vision of this research program is to bring an integrated approach that synergizes
computational tools and experimental validations, to deepen our foundational knowledge of
glycan-collectin interactions and their broader implications.

Public health relevance
Project Narrative Bacteria communicate through molecules on their surface, called glycans, which can help them invade our bodies. Our research investigates these molecules and how they interact, using advanced computational techniques. In doing so, our goal is to advance our knowledge of bacterial glycan behavior, leading to new ways to enhance health and prevent infections.